Diurnal Variation in Acetylcholine Modulation of Dopamine Dynamics Following Chronic Cocaine Intake

Project Summary
In 2020, an estimated 5.2 million Americans reported using cocaine, with 1.3 million meeting criteria for Cocaine
Use Disorder (CUD). Despite the increasing need, there are no FDA-approved treatments for CUD. One variable
that is often overlooked in CUD research is the resulting disruption of circadian (24-hour) and diurnal (night/day)
rhythms. Disrupted rhythms have been shown to prolong the cycle of cocaine abuse and increase the risk of
relapse. CUD can be modeled with cocaine self-administration (SA) using three different patterns of cocaine
intake: short continuous access (ShA), long continuous access (LgA), and intermittent access (IntA). Though our
lab has established diurnal variation in rhythms of dopamine (DA) dynamics, including cholinergic interneuron
(CIN) modulation and DA reuptake in naïve animals, it is not yet understood how adapting the type of cocaine
SA intake pattern differentially affects these rhythms and the mechanistic pathways involved following long-term
cocaine intake. The mesolimbic DA system in the nucleus accumbens core (NAc) is an important mediator of
motivated and reward-associated behaviors that are maladapted in CUD. CINs are critical modulators of
mesolimbic DA release in the NAc via their activation of acetylcholine (ACh) receptors on DA terminals. While
the effects of chronic cocaine on DA signals and CIN/ACh activity have been studied extensively at single time
points, a major obstacle in the field is that cocaine-induced changes in DA signaling rhythms and potential
mechanisms for rhythmic disruptions, such as alterations in CIN signaling, have not been investigated. Thus,
my central hypothesis is twofold: 1) to discover the effect of long-term, voluntary cocaine intake on time-
of-day rhythms in DA and ACh NAc signaling, and 2) outline a mechanistic link between rhythms of ACh
and DA signaling. The proposed research plan will examine the role of rhythms in DA release and CIN activity
under various patterns of cocaine access with the following aims: (1) Assess the cocaine history and pattern of
intake on diurnal variation in NAc DA release, (2) Examine a mechanism for disrupted diurnal rhythms in DA
release in cocaine-exposed animals, and (3) Define the temporal architecture of CIN modulation of DA release
magnitude in cocaine-exposed animals. These studies will highlight the importance of endogenous diurnal
rhythms in NAc neurochemistry following chronic cocaine intake patterns to provide greater mechanistic insight
into the role of rhythms in CUD. Understanding the influence of rhythms underlying CUD neurochemistry will
provide novel treatment targets and propose times throughout the day in which to target them most effectively.

Public health relevance
Project Narrative Of the estimated 5.2 million Americans reporting cocaine use in the year of 2020, 1.3 million met the criteria for cocaine use disorder (CUD) – a disease for which there are no FDA-approved treatments. Cocaine-induced disruptions of circadian (24-hour) and diurnal (night/day) rhythms are significant risk factors for the development of CUD and relapse. The proposed studies will examine the influence of chronic cocaine intake patterns on diurnal rhythms of acetylcholine and DA release to provide new mechanistic targets and pose times throughout the day that may be most effective in treating CUD.